Pulmonary Biostatistics Core

PROJECT SUMMARY/ABSTRACT
Core E
The Core will provide severe asthma investigators from each of the three Projects all facets of statistical support,
including experimental design, analysis, and interpretation. Core personnel will interact with PPG investigators
in all stages of research, including the formulation of research questions and hypotheses, experimental design,
data management, data analysis, result interpretation, preparation of scientific manuscripts and grants,
dissemination of results, and the assessment of stepwise success and barriers to meeting overall project
objectives. Specific aims are: (1) to collaborate with project investigators to ensure that all clinical and
translational studies and experiments are properly designed, and (2) to provide support to project investigators
in the statistical analysis and reporting of data from experiments and clinical studies. These aims will be
accomplished by a team consisting of Yi Zhao, PhD (core director) and James Slaven, MS providing biostatistical
support and expertise. There is no comparable core for pulmonary data analysis at IU, though there are
complementary programs for Computational Biology and Bioinformatics.